Cell Death Programs as Fundamental Drivers of Inflammation and Multi-Organ Injury

Project Summary/Abstract
Inflammation is an essential component of vertebrate immunity against invading pathogens,
foreign insults, or abnormal physiologic conditions. Cellular death programs, meant to eliminate
infected, insulted, or abnormal cells, constitute frontline mechanisms in innate inflammation.
Release of immunogenic cellular materials from dying cells contributes to the initial stages of
inflammation (also called acute inflammation). Even though this process is meant to be
protective, the loss of vital cells from infected/affected organs often results in acute tissue injury.
As infection/insult is mitigated, acute inflammation is resolved with onset of tissue repair
processes. However, if insult/infection continues, acute inflammation is not resolved. The
persistent inflammation continues to injure tissues and subsequently leads to fatal organ
damage. This process manifests in systemic diseases such as sepsis. The challenge remains in
understanding how fundamental drivers of inflammation contribute to protective versus injurious
inflammation. This knowledge is essential to design targeted intervention strategies against
damaging inflammation without impeding protective inflammation. In this proposal, we will
characterize how cellular death programs contribute to both protective and injurious
inflammation in immune and non-immune cells during bacterial infections. We recently show
that cell death-associated proteins, apoptotic caspase (CASP)8, necroptotic receptor interacting
protein kinase (RIPK)3- and CASP8-RIPK3-associating partner RIPK1 dictate endotoxemia,
pulmonary inflammation and sepsis in mice. CASP8 and RIPK3 amplify injurious inflammation
while RIPK1 plays a protective role. These observations highlight that different components of
cell death signaling contribute differentially to pathogen-induced diseases. Based on this
evidence the central hypothesis of this proposal is: Members of cellular death signaling dictate
both beneficial and injurious inflammation during multi-organ injury and must be targeted
accordingly for therapy. In the specific aims of this proposal, we will utilize human cells, murine
genetics, knockdown/knockout strategies to characterize how cell death-associated proteins
contribute during bacteria-induced inflammation. We will also test chemical and new biological
suppressors of cell death as anti-inflammatory strategies in these settings. This proposal is
transformative in its potential to identify novel signaling steps of inflammation as well as future
therapy targets. This proposal also retains a primary focus on training undergraduate students
in research with the aim of preparing next generation of immunology researchers.

Public health relevance
Project Narrative: Proteins driving cellular death programs contribute to inflammation underlying tissue injury during infectious diseases. How they contribute in different cells to dictate protective versus injurious inflammation remains unresolved. We hypothesize that during critical illness or sepsis some members of cellular death programs contribute to essential protective inflammation, whereas other members emerge as potential therapy targets as they drive injurious inflammation.